The Heart of the Matter: Prioritizing diversity and inclusivity in the Resuscitation Science Symposium 2024

ABSTRACT
The Resuscitation Science Symposium (ReSS) is an annual specialty conference of the American Heart
Association, Council on Cardiopulmonary, Critical Care, Perioperative and Resuscitation (3CPR). The first
meeting was held as a pre-conference in 2003, bringing together leading scientists and investigators dedicated
to improving outcomes from cardiac arrest. Today, the symposium is a 2-day event with approximately 50
multidisciplinary conference faculty presenting innovative and novel science to an international audience.
ReSS has evolved over the years, with a focus on advancing the careers of early scientists, building a diverse
and inclusive community for inquiry, and expanding into scientific realms that encompass all aspects of the
cardiac arrest “Chain of Survival.” Since it's inception, ReSS has included events to promote early-career
scientists by hosting a Young Investigator Networking Event the night prior to the start of official scientific
proceedings, as well as an annual Women in Resuscitation Event that varies in content from open forum
discussion to career coaching. ReSS also boasts a phenomenal track record of being the forum for
presentation of ground-breaking research, including topics such as targeted temperature management and
dual sequential defibrillation. It is a meeting where thought-leaders debate outcomes, create collaborations,
and plot a pathway forward to improve outcomes from cardiac arrest. In light of this opportunity, the
programming committee for ReSS recognizes the strength in diverse, collaborative teams. We are firmly
committed to growing the pipeline of future investigators in cardiac arrest research. To that end, we recognize
the importance of a diverse and inclusive team that sponsors and grows investigators for all demographic,
region, and specialty. This proposal to the NIH is requesting support to provide resources to individuals who
are young investigators, members of underrepresented groups, attendees what might have hardship travelling
due to caregiving needs, financial hardship or disability. The ReSS programming committee is invested in
growing our community as a means of creating novel inquiry that will undoubtedly improve outcomes from
cardiac arrest.

Public health relevance
PROJECT NARRATIVE The Resuscitation Science Symposium (ReSS) is a premier international conference sponsored by the American Heart Association to advance knowledge and improve outcomes from cardiac arrest. The programming committee for ReSS is dedicated to making the meeting a diverse and inclusive environment that will promote the advancement of science and scientists engaged in work related to cardiac arrest. To that end, we are requesting additional scientific meeting support to sponsor participation by persons from underrepresented groups, women, early-career scientists/trainees, and survivors/co-survivors/rescuers in order to enhance the dialogue and promote early career scientists.